Control of Axon Initial Segment in Epilepsy

Temporal lobe epilepsy (TLE) is the most common epilepsy in adults, and it is frequently refractory to current
anti-epileptic drugs, with treatments often exerting a variety of debilitating side effects. A major barrier for the
development of novel treatment strategies is our insufficient understanding of the precise cellular and circuit
mechanisms underlying TLE. A centrally important but unresolved question in TLE concerns the mechanisms
underlying the excessive, dysregulated production of action potentials at the axon initial segment (AIS) of
excitatory principal cells (PCs). Synaptic control of AIS is provided by a unique, evolutionarily conserved,
GABAergic cell-type, the axo-axonic cells (AACs). AACs form synaptic contacts exclusively with the AIS of
PCs, placing AACs in a strategic position to control action potential generation. However, due to technical
limitations, our knowledge about the in vivo function and regulation of AACs in the normal and epileptic
hippocampus has been extremely limited. Here we propose to employ a combination of recent technical
breakthroughs to test hypotheses about the in vivo functional effects, activity dynamics and efficacy of AAC-
mediated control of AIS in mouse models of chronic TLE. The planned project will also determine if it is
possible to mitigate epilepsy-related pathologically hyperactive circuits and cognitive deficits through
interventions selectively directed at the AAC-dependent, endogenous GABAergic processes regulating AIS in
chronic epilepsy. The proposed project aims to fill a major knowledge gap and address long-standing
controversies concerning the interneuronal regulation of AIS in epilepsy by leveraging expertise in novel large-
scale, high-resolution in vivo functional imaging techniques in combination with advanced electrophysiological,
behavioral, optogenetic and computational modeling techniques in the CA1 region of the mouse hippocampus.
It is anticipated that defining the function, regulation and therapeutic potential of AACs in TLE will have a
significant impact by advancing our understanding of key circuit control mechanisms in chronic epilepsy and
aid the future development of novel anti-epileptic treatment strategies.

Public health relevance
Many patients with temporal lobe epilepsy have repeated spontaneous seizures that cannot be controlled with existing drug therapies. Epileptic circuit activity is characterized by excessive production of electrical signals at a specialized part of brain cells called the axon initial segment that is innervated by a unique but poorly understood regulatory interneuron. In this project, we will leverage recent technical breakthroughs to determine mechanisms underlying alterations in the ability of these interneurons to control abnormal electrical activity patterns in chronic temporal lobe epilepsy and evaluate the efficacy of closed-loop interventions directed at these cells for seizure control and amelioration of cognitive deficits.